A novel platform for targeted radiopharmaceuticals for imaging and therapy of ovarian cancer

Project Summary
The goal of this Phase I STTR is to continue development of Oncurie’s novel ovarian cancer targeting
compound, which binds to the folate receptor and delivers radionuclides suitable for targeted imaging and
therapy with a proprietary moiety. The disease is difficult to detect in early stages with an estimated 75% of
women presenting with advanced disease at the time of diagnosis. The mortality rate of ovarian cancer is one of
the least improved in recent years, with 5-year survival rates for stage III and stage IV disease estimated at 42%
and 26%, respectively. These factors highlight the urgently unmet need for new diagnostic tools and therapeutic
strategies for this devastating disease which impacts over 20,000 women per year in the US, resulting in
approximately 14,000 deaths. Oncurie has developed a targeted radiopharmaceutical platform enabling
precision imaging of ovarian cancer with future developments towards therapy. The compound includes two key
features: 1) a folate receptor (FR) binding moiety to exploit the receptor’s well-documented overexpression in
ovarian cancer; and 2) Oncurie’s proprietary radionuclide-binding domain which binds radioisotopes with high
affinity preventing in vivo dissociation from the core compound resulting in improved safety and targeting efficacy.
In collaboration with Suzanne Lapi, PhD of the University of Alabama at Birmingham, the company has shown
that the compound (O5) binds ovarian cancer cells with sub-nanomolar affinity and is internalized to the nucleus.
In vivo, O5 has been shown to specifically target the folate receptor present on ovarian cancer tumors in
xenograft models. During Phase I, we will refine the molecular structure and formulation of the compound to
improve synthetic scalability, ease of handling and ensure radiolabeling chemistries remain reliable and efficient.
In vitro testing will be undertaken to confirm the compound’s FR-targeting properties in a range of ovarian cancer
cell lines. Finally, the compound will be evaluated in a patient-derived xenograft (PDX) model of ovarian cancer,
which more closely resembles human disease pathogenesis compared to the xenograft model used for initial
proof-of-concept studies presented in the Preliminary Data section. Pending successful completion of these
Phase I Aims, a subsequent Phase II program will advance the compound through critical safety, toxicology, and
efficacy testing required for submission of an Investigational New Drug (IND) application to the FDA to enable
clinical studies. It should also be noted that, while Oncurie’s current strategy is to evaluate this compound for
radiographic imaging and disease diagnosis, the same compound is intended to be used as a therapeutic when
paired with a cytotoxic radionuclide as part of a theranostic strategy. Currently marketed radiotherapeutics such
as Lutathera and Pluvicto employed a similar strategy, developing a diagnostic imaging agent first, followed by
the development of a therapeutic with effectively the same core molecule. Oncurie’s product is estimated to
have similar revenue potential compared to these products, reportedly ranging from $500 million to $1 billion.

Public health relevance
Project Narrative Ovarian cancer is often only detected in late stages which limits treatment strategies and results in poor 5-year survival statistics. Oncurie has developed a novel targeted imaging radiopharmaceutical, O5, which selectively targets the folate receptor, a surface protein known to be upregulated in a range of malignancies including ovarian cancer. To date, O5 has been shown to reliably bind to ovarian cancer cells through the folate receptor and reveals xenograft tumors in murine models. This Phase I program will refine the structure, test its effectiveness in other ovarian cancer cells, and evaluate its ability to target human-derived cancer cells in murine models.